Pathological B Cells: Novel Strategies to Prevent and Treat Chronic GVHD

ABSTRACT
In this renewal, we continue efforts to develop agents that will make allogeneic hematopoietic stem cell
transplantation (HCT) less toxic for patients. Our major objective is to develop strategies that target chronic graft
versus host disease (cGVHD)-related immune pathology without blocking the critical immunotherapeutic effects
of HCT. B cells have a substantiated pathobiological role in cGVHD, but distinguishing disease-mediating B cells
subsets remains elusive. Targeting only aberrant B cells is important because we have found that global
abrogation of peripheral B cells with rituximab perpetuates so-called altered immune homeostasis and cGVHD
in patients unable to recover a comprehensive B-cell compartment. In the previous funding period, we elucidated
how pathological B Cell Activating Factor (BAFF) and NOTCH2 promote aberrant B Cell Receptor (BCR)-
signaling after HCT. Based on known BCR signaling events during B cell maturation, we hypothesized that
antigen-hyperresponsive and SYK-reliant B cells can be eliminated without affecting immune homeostasis. In
preclinical studies and in the clinical trial, we showed that inhibition of the BCR-proximal protein, SYK, eliminated
aberrantly activated B cells and afforded recovery of B-cell homeostasis. We have also begun to dissect novel
mechanisms underpinning BCR hyper-responsiveness. Published evidence and our additional preliminary data,
including a single cell RNA-Seq dataset, form the solid scientific basis for this proposal and afford our current
overarching hypothesis that aberrant activation and effector function pathways in B cells can be effectively
targeted in cGVHD. In the current proposal, we address major gaps in our knowledge regarding human B-cell
programming that confer a propensity for ongoing loss of B cell tolerance in cGVHD. Our experimental approach
entails study of cGVHD patient samples in our ex vivo B-cell assay system and parallel experiments in mice
using B-cell conditional and inducible knockout mice as donors to verify molecular mechanisms. Specifically, we
will delineate molecular pathways that promote pathological B cells and determine the distinct disease-mediating
functions of cGVHD B cells. We will pursue three specific aims: 1) persistence of SYK protein after BCR
engagement, 2) the ability to block SYK and restore humoral immunity in cGVHD patients in a Phase II clinical
trial 3) molecular underpinnings of antibody and inflammatory cytokine production. We will define targetable
signaling pathways in B cell subsets that we will show have pathological B-effector cell functions in cGVHD. Our
proposal relies on a team science concept and is made possible by co-investigators on the Duke clinical trial
team (Drs. Horwitz and Rizzieri) and Duke Cancer Institute statistical group (Drs. Li and Owzar). Our group
remains at the forefront of efforts elucidating aberrant human B-cell signaling and testing small molecule
inhibitors in chronic GVHD patients.

Public health relevance
NARRATIVE Allogeneic haematopoietic stem cell transplantation (HCT) is the standard therapy for several haematological cancers and diseases with more than 30,000 procedures carried out annually worldwide, including in 40 per 100,000 Americans afflicted with life-threatening blood, bone marrow or lymph node cancer. Immune pathology called chronic graft versus host disease (cGVHD) develops in many HCT patients, leading to significant impact on morbidity and survival. Our current research will advance knowledge of cGVHD immune mechanisms in human HCT that will lead to improved treatments for cancer patients, and patients with autoimmune and blood disorders.